Investigation of sub-lineages in pulmonary neuroendocrine cells and identification of the cells of origin of small cell lung cancer

PROJECT SUMMARY
Small cell lung cancer (SCLC) remains a major challenge in public health because of its frequency, its lethality, and
the paucity of convenient models for exploring its pathogenesis and potential therapeutic strategies. Pulmonary
neuroendocrine cells (PNECs) are believed to be the putative precursor of SCLC. However, increasing evidence shows that
PNECs contain sub-lineages varying in location, cell size, and physiological functions.
In my previous research, I developed a novel experimental approach for studying the biology of PNECs - and the
initiation of SCLC - by differentiating human embryonic stem cells (hESCs) into the lung lineage, and subsequently
perturbing three tumor suppressor genes that are frequently altered in SCLC. By perturbing NOTCH signaling, the lung
progenitor cells can be differentiated into PNECs that further undergo oncogenic transformation and form SCLC-like tumors
in mice, when RB and P53 expression are reduced. Single cell RNA (scRNA) profiles demonstrated great similarity between
the hESC-derived PNECs and the native PNECs in human and mouse lung. Of particular significance, scRNA analysis
further revealed sub-lineages within the hESC-derived PNECs. Among them, one profile demonstrated significant similarity
to the RNA profiles of early stage human SCLC tumors and SCLC cell lines. The above findings and recent studies by
others, led me to further hypothesize that the PNEC sub-lineages have different oncogenic potential, and among them, one
specific population serves as the dominant cell of origin of SCLC.
I propose to use this model together with other methods such as scRNA transcriptomics, genetically engineering
mouse models, to test this hypothesis and to study the origins of SCLC in several ways. First, I will identify the PNEC sub-
lineages in normal human and mouse lung tissues that are similar to the ones in the hESC-derived PNECs. Alternatively,
sub-lineages of PNECs in mouse lung will be characterized by scRNA profiling and new cell-fate markers identified from
the mouse PNEC sub-lineages will be extrapolated to further delineate the heterogeneous populations in human PNECs.
Next, I will purify the sub-populations of hESC-derived PNECs and test their transformative potential in culture and in
immunocompromised mice by known oncogenic events in SCLC. Alternatively, the PNEC sub-lineages in mouse lung can
be tested for their potential to form tumors by using conditional Rb1/Trp53 knockout mice. Through these studies, I expect
to identify a specific sub-lineage of PNECs that are most sensitive to SCLC mutations and capable of transformation, which
would implicate them as the cell of origin in SCLC.
In the R00 phase, I propose to expand the research to explore mechanisms driving the lineage hierarchies of PNECs
and their variant oncogenic potentials. These include studying inter-differentiation among the PNEC sub-lineages, the
effects of NOTCH, SOX2 and other single pathways on PNEC fate determination, and using CRISPR screening to explore
new molecular events important in maintenance of PNEC hierarchical patterns and the regulation of their specific oncogenic
capacity. These studies are expected to not only advance our understanding of carcinogenesis of PNECs, but also provide
new opportunities to diagnose, categorize, treat, and possibly even prevent this disease more effectively.

Public health relevance
PROJECT NARRATIVE Identifying the cell types that give rise to small cell lung cancer (SCLC), a major health problem in the United States, would not only constitute an important advancement for the field, but also provide new methods to diagnose and treat this disease more effectively. Several lines of evidence include our data suggesting that pulmonary neuroendocrine cells (PNECs - the putative normal precursors to SCLC) are heterogeneous, and contain sub-lineages of cells with different capacities for SCLC transformation. I now propose to employ our human embryonic stem cell (hESC)-based SCLC model, combined with the technologies of single cell profiling and CRISPR screening, to study the PNEC hierarchies and to more accurately identify the cell types or subtypes that SCLC originates from.